Wisconsin Exploratory Center for Interdisciplinary Research in Benign Urology

ADMINISTRATIVE CORE PROJECT SUMMARY The goal of the Wisconsin Exploratory Center for Interdisciplinary Research in Benign Urology is to build a dedicated team of experienced investigators from diverse fields who will conduct clinical and health services research in benign urology and genitourinary conditions and inspire and train the next generation of researchers. The Administrative Core will provide leadership and infrastructure for the Wisconsin Exploratory Center for Interdisciplinary Research in Benign Urology. It will provide administrative support to the Research Project and the Educational Enrichment Program. The Administrative Core will facilitate internal Center communication through weekly meetings with Center investigators, which will also be open to affiliated trainees and students. The Administrative Core will maintain a public-facing Center website. It will promote synergistic research efforts across the Wisconsin Exploratory Center and other NIDDK-funded programs and centers.